The effects of cochlear pericytes and pericyte-related vascular pathology on hearing function

PROJECT SUMMARY
Hearing loss has a profound impact on individuals, causing communication problems, social isolation, and cognitive
decline. Microvascular pathology is a significant factor seen in many types of hearing loss, including sound-induced
hearing loss, age-related hearing loss, genetic hearing loss, and autoimmune inner ear disease. Normal capillary
blood flow is highly controlled by pericytes. The pericytes, specialized mural cells surrounding small blood vessels
adjacent to endothelial cells, are vital for normal vascular function. Pericyte pathology, such as pericyte loss or
degeneration, is a significant factor in degenerative neural diseases, including Alzheimer's disease and brain
dementia. The cochlear microvasculature contains an abundant population of pericytes. However, the role of
pericytes in the cochlea, in general, is understudied. In particular, their roles in vascular and hearing function is
largely unknown. Using a combination of well-established and cutting-edge techniques, and building on preliminary
data produced under R21 support, the proposed five-year research program continues the investigation of
mechanisms outlined in our current R21 grant to further explore the role of PCs, PC-related vascular pathology,
and angiogenesis in cochlear health. Success in this project will open new clinical options for treatment of aging-,
noise exposure-, and genetic vascular deficiency-related deafness in which PCs are compromised.

Public health relevance
PROJECT NARRATIVE Insufficient blood flow to the cochlea is a significant pathological factor in the indifferent types of hearing disorders. Hearing loss profoundly affects individuals, causing communication problems, social isolation, and cognitive decline with high incident of Alzheimer's disease. Targeting repair of vessels, in conjunction with other therapies for hair cell regeneration, will open new avenues for hearing restoration.